PRedoctoral Interdisciplinary training in renal physiology and MEdicine (PRIME)

Summary/Abstract
The UAB PRedoctoral Interdisciplinary renal physiology and MEdicine (PRIME) training program (Jennifer S.
Pollock, PhD, Director; Paul Muntner, PhD, Associate Director) builds on established strengths in the kidney
community at UAB incorporating basic, clinical, translational, and epidemiological investigation. The PRIME
program brings together the Divisions of Nephrology, Pediatric Nephrology, Nephrology Research and Training
Center (NRTC), Cardio-Renal Physiology and Medicine Section, O'Brien Center for Acute Kidney Injury,
Center for Free Radical Biology (CFRB), Hepato-Renal Fibrocystic Center, HudsonAlpha Institute of
Biotechnology, Departments of Cell, Developmental, and Integrative Biology, Pathology, Pathology, Surgery,
Nutrition Sciences, Urology, Pediatrics, and Epidemiology providing a vibrant and effective interdisciplinary
training environment and curriculum. These units enable an integrated and interdisciplinary landscape of
collaborative science, which ranges from fundamental molecular discovery to translational and epidemiological
research. These divisions, centers, and departments are all engaged in initiatives to build on state of the art
kidney research with empowering and engaging faculty committed to training. This program includes
established faculty and an explicit effort to incorporate young faculty to further strengthen the outstanding
mentoring environment promoting development of all phases of this program. An effective interdisciplinary
training program requires faculty with collaborative and synergistic scientific interests and projects, as well as
systematic coordination of training opportunities facilitating promotion of life-long kidney investigators. The
collaborative environment at UAB, embodied by the centers, programs, sections, and departments in this
application, provides a strong research foundation. The committed training environment of the thematically
organized Graduate Biomedical Sciences program in the School of Medicine, the graduate program in the
Department of Epidemiology in the School of Public Health, and an outstanding UAB Office of Graduate Affairs
and Postdoctoral Education, provide an ideal setting for the implementation of training in interdisciplinary
kidney disease research. The training program is requesting 3 predoctoral training slots and expansion to 4
predoctoral slots in years 3, 4, and 5 (3-3-4-4-4) with each trainee participating in the program for 2 years with
an optional third year.Required coursework will be incorporated into the individual development plan (IDP) of
each trainee, which will be augmented by a broad interdisciplinary enrichment program. An executive
committee will provide leadership for the PRIME program. The PRIME Internal Advisory Committee and
PRIME External Advisory Committee will evaluate the overall performance of the PRIME Program. A series of
benchmarks for progress will be formulated for each trainee and mentor and reviewed on a semi-annual basis.
The members of the UAB training faculty are fully committed to continuing to provide mentorship, support, and
guidance to graduate students to help them develop the tools and skills necessary to advance kidney disease
research and be life-long kidney researchers.

Public health relevance
Narrative This PRedoctoral Interdisciplinary renal physiology and MEdicine (PRIME) Training Program at UAB enables vibrant, interdisciplinary, fundamental, translational, and epidemiological research training. There is a large, diverse faculty with interests centered on kidney and kidney-related physiology and pathophysiology research; epidemiology, outcomes and prevention; experimental therapeutics and biomarkers; genetics and functional genomics; and mediators of kidney disease. The training faculty, resources, and environment provide an exceptionally strong mentoring environment to train the next generation of kidney disease researchers.